Community Liason and Recruitment Core

The public health impact of interventions is often not realized because stakeholders have not been involved in
the development of preventive strategies or interventions intended for them. Johns Hopkins researchers have
been at the forefront of Community-Based Participatory Research methods for over a decade.4-9 As an
approach, CBPR promotes community-academic partnerships in which community members and/or recipients
of interventions are involved in all phases of research, including (1) identifying the health issues of concern to
communities; (2) developing assessment tools; (3) collecting, analyzing, and interpreting data; (4) determining
how data can be used to inform actions to improve community health; (5) creating the research designs; (6)
designing, implementing, and evaluating interventions; and (7) disseminating findings. The overarching goal of
the Community-Liaison and Recruitment Core (CLRC) is to communicate and collaborate with community
organizations to increase the translation of the preventive strategies and interventions that are developed.
Developing and sustaining community partners, as well as training and engaging JHAD-RCMAR Scientists in
community-engaged research will reflect collaborative and synergistic work with other JHAD-RCMAR Cores.
Specifically, the CLRC will work with the Leadership and Administrative Core to develop collaborative
relationships with communities of faith, and community-based organizations as partners in designing
interventions to ameliorate health disparities in cognitive impairment and ADRD in minority older adults;
and identify and develop culturally appropriate mechanisms for disseminating information about AD/ADRD and
about related research results. The CLRC will also be guided by the Research Education Component to
establish new or adapt evidence-based intervention models that embrace community participation and future
trial results for minority older persons; train RCMAR scientists, investigators, and lay consumers about
community-engaged research, including the ethical dimensions; and develop the JHAD HBCU Initiative. In
addition, the CLRC will collaborate with the Analysis Core to enhance the capacity of representatives of
community-based organizations, faith communities, and primary care practitioners to participate in research as
partners in inquiry; and study recruitment and retention of older participants in ADRD-relevant research,
particularly minority older adults. By blending features of ‘clinical’ and ‘community’ approaches, we can better
address health disparities and have a significant public health impact on the health and well-being of an aging
population.